AN INTEGRATED PLATFORM FOR NOVEL PERSONALIZED LIVER CANCER THERAPEUTICS

SUMMARY
Hepatocellular carcinoma (HCC) is a major health problem, with increasing mortality rates. In the US, HCC
mortality is strongly affected by race/ethnicity and the highest mortality is found among racial minorities such as
Black, Indigenous and People of Color (BIPOC). This is partly due to (a) limited efficacy of current FDA-approved
therapies and (b) a lack of personalized (biomarker-guided) therapeutic options, which is compounded by a lack
of HCC preclinical models from diverse race-ethnic backgrounds.
Thus, there is an urgent need to identify novel personalized therapeutic options that are validated in
preclinical HCC models that represent the racial/ethnic diversity observed in HCC patients.
In this proposal for a supplement to our parental RO1, we expand our original team to integrate new expertise
in equity research, qualitative analytics, communications research community-based participatory research,
implementation, and organizational research (Mohamed, Bickell), to the existing one in clinical management of
liver disease (Villanueva), chemical biology (Dar), HCC animal models (Lujambio) and patient derived-organoids
and 2D lines (Guccione).
The major hypothesis that we seek to test is that BIPOC patients will report significant barriers to tissue
donation and that by facilitating the creation of such preclinical models (i.e. PDO) from diverse etiology and a
broad spectrum of ethnic/racial backgrounds, we will identify differences in drug efficacy and toxicity in relation
to specific tumor genetic and epigenetic backgrounds.
We propose to (a) Elucidate BIPOC HCC patients’ barriers and facilitators to donate tissue; (b) Develop and
test a culturally tailored educational intervention for diverse racial-ethnic groups, to encourage tissue donation
from HCC patients; and to (c) Establish better preclinical models (i.e. patient derived organoids, PDOs) that take
into account differences in etiology and racial-ethnic background. The latter models will then feed into our original
pipeline for drug screening, with the aim to identify new precision therapeutic leads.
The proposed research will increase our understanding of the barriers that limit or enable tissue donation
from BIPOC HCC patients and to tailored intervention strategies to improve availability of preclinical models from
BIPOC patients, ultimately resulting in improved preclinical studies and translation into the clinics.
Key deliverables include new preclinical models and leads for drug discovery derived from well-validated
chemical starting points and mechanistic insights into patient stratification and therapeutics for HCC.

Public health relevance
NARRATIVE Despite increasing racial/ethnic disparities in HCC mortality rates, there is a lack of diverse preclinical models that capture the distinct racial/ethnic groups and that can be used for drug screening studies. In this project, we will investigate the upstream barriers and facilitators for Black, Indigenous and People of Color (BIPOC)-HCC patients to donate tissues for preclinical research and develop a culturally-tailored educational intervention for diverse racial/ethnic groups to encourage such donations. We will finally generate establish preclinical models (i.e. patient derived organoids/PDOs) that take into account such differences in etiology and racial-ethnic background to advance new class of lead compounds for precision-based therapeutics in HCC.